Shared Resource-Mass Spectrometry Core-Proteomics and Metabolomics

Mass Spectrometry Core: Proteomics and Metabolomics Shared Resource - Project Summary/Abstract
Since the last renewal, the Mass Spectrometry Core: Proteomics and Metabolomics has been significantly
upgraded, including a new Director and staff, the purchase of state-of-the art instrumentation, expansion of
Core proteomics services, and the introduction of metabolomics services. By improving every aspect of
service, the Mass Spectrometry Core provides Cancer Center members with the highest level of support for
their proteomic, metabolomic, and custom peptide synthesis needs. The Director and Associate Director
provide expert consultation concerning the design, implementation, and analysis of a wide range of
experiments including: protein identification, protein quantification, identification of post-translational
modifications, secreted protein/peptide analysis, untargeted lipidomics profiling, targeted lipidomics and
metabolomics, bile acids analysis, amino acid quantitation, fatty acid analysis, and custom peptide synthesis.
In recent years, five new mass spectrometers have been acquired and a highly experienced Core staff, with
strong working knowledge of a wide range of proteomics and metabolomics applications, has been recruited to
oversee this facility. The staff provides the knowledge and technical skills to get the most out of this
sophisticated new equipment. The Core staff are constantly working to implement new analytical techniques in
these rapidly evolving fields while supporting researchers with data analysis, as well as manuscript and grant
preparation. Peptide synthesis services have recently been consolidated into this Core and offer custom
services for synthesis, HPLC purification, and mass spectrometry-based analysis of peptides, including long
peptide syntheses and custom modifications. This Core is broadly used by the vast majority of Cancer Center
members, and the staff remain dedicated to meeting and advancing their research. The Core strives to
facilitate cancer research by: 1) providing sophisticated instrumentation for discovery: the Core has five high-
resolution mass spectrometers (three for proteomics and two for metabolomics) and one peptide synthesizer,
2) providing expertise: decades of combined experience from the Core staff are made readily accessible to
Salk investigators for consultations concerning experimental design, data acquisition and analysis, and
manuscript and grant preparation, 3) providing critical services: The Core staff provides reproducible, high-
quality sample preparation services prior to metabolic and proteomic analysis, as well as providing custom
peptide synthesis and purification, 4) providing education, training, and support: Salk researchers at all levels
of expertise can receive training in the successful applications of mass spectrometry for proteomic and
metabolomics analysis, particularly with respect to experimental design and data analysis, and 5) identifying
and evaluating new technologies: the Core seeks to ensure that it continuously offers state-of-the-art
instrumentation and validated technological advances to enhance discovery as a result of the Core users'
experiments.